EVALUATING ORAL HEALTH STATUS AS IT RELATES TO PROBLEMATIC EATING BEHAVIORS

The nutritional status of the elderly has been studied extensively but little is known about how oral health status relates to problematic eating behaviors among nursing home residents. Because of a dearth of information, dentistry is often excluded from inter- disciplinary strategies for treating dysphagia. If oral health problems are identified as contributing to malnutrition, weight loss, or the eventual placement of a feeding tube, then appropriate oral health interventions may improve the quality of life for nursing home residents. Literature reviews have been conducted to identify research questions and hypotheses. Collaborations have been established with extramural scientists as preparation for investigations in this area. Data collection for an initial project examining the role of oral health status in the development of problematic eating disorders among nursing home residents has recently been completed. Oral health data is being linked to relevant clinical, social, cultural, and environmental data which are part of a parent study being conducted by an extramural collaborator at the University of California, San Francisco. Interpretation of the results of this study should augment the rationale for improved recognition and treatment of presenting dental needs within this underserved population.